Culturally-focused HIV Advancements through the Next Generation for Equity (CHANGE) Training Program

Project Summary/Abstract
Science is failing minorities in the US by 1) not facilitating adequate pipelines for the professional
development of minority scientists and 2) not focusing adequate research on the disparities affecting minority
populations. This proposed institutional training grant (T32) targets this gap by providing robust research
training on HIV and mental health disparities that impact racial/ethnic minorities and establishing a pipeline to
support underrepresented Black and Latinx trainee scientists. Preparing trainees with the scientific tools to
become experts in the complex interplay of socio-structural and individual mental health variables perpetuating
disparities in HIV outcomes is crucial to ending the HIV epidemic. HIV continues to disproportionally impact
Black and Latinx communities in the US; and Miami remains the epicenter of HIV with most new HIV
diagnoses annually. Miami’s racial/ethnic, cultural, and sexual/gender diversity, its HIV-related health and
mental health disparities, and the training infrastructure and faculty expertise at the University of Miami (UM),
make Miami an ideal location for this HIV mental health research training program.
The proposed T32 is closely tied to the aims of the UM Center for HIV and Research in Mental Health
(CHARM, an NIMH-funded Developmental AIDS Research Center; D-ARC). It will train two underrepresented
pre-doctoral students in psychology and public health sciences and up to 4 post-doctoral fellows across
disciplines over 5 years in two linked areas: 1) culturally informed interventions for racial/ethnic, sexual, and
gender minority populations and 2) innovative bio-behavioral interventions including scale up, linkage, and
dissemination/implementation programs for pre-exposure prophylaxis (PrEP) and treatment as prevention
(TasP) in populations who need it most. Training will emphasize 1) innovative state-of the science statistical
and design methods, 2) community engagement through participatory research, and 3) professional
development, mentorship, and network building congruent with the needs of racial/ethnic trainees focused on
minority populations - all to ensure long-term success of program graduates. These focal areas are closely
aligned with NIH/DAIDS goals, CHARM expertise, UM public health and psychology faculty, and UM’s
roadmap for racial justice. Innovations include a focus on immersive community engagement and community-
based participatory research projects, integrated with coursework and training in key behavioral science topics
such as socio-structural, bio-behavioral and epidemiological foundations of HIV/mental health research.
Weekly seminars will provide professional development in rigor and reproducibility, innovative methods,
community-engaged research and immersion in the HIV and mental health fields, building professional
networks, capitalizing on UM’s faculty mentoring expertise, and providing linkages with the CHARM
Community Advisory Board. T32 fellows will graduate with the expertise and capacity to achieve their
professional goals and skills to conduct research to reduce HIV disparities in Black and Latinx communities.

Public health relevance
Project Narrative There is an urgent need to increase the diversity of independent investigators both generally and in HIV-related behavioral health research in particular. Miami is an HIV epicenter, with new diagnoses disproportionately impacting underrepresented racial and ethnic minorities. The proposed (CHANGE; Culturally-focused HIV Advancements through the Next Generation for Equity) training program, tied to the University of Miami’s Center for HIV and Research in Mental Health (CHARM), will fill this gap by training underrepresented Black and Latinx predoctoral and post-doctoral behavioral scientists in research related to HIV and mental health disparities, aligned with the NIH NOT-OD-20-031 on diversity.